Genomic approach to identification of microglial networks involved in Alzheimer disease risk

Project Summary
Alzheimer's disease (AD) is the only disease among the top ten killers in the U.S. without a disease modifying
therapy. Genetic studies provide a powerful means to identify genes and pathways that are causally linked to
disease etiology. Technological advances have substantially reduced the cost of genomic analyses enabling
the generation of large publicly available datasets that can be integrated to perform multi-scale analyses.
Hypotheses generated from these data can then be validated in cell and animal models. A major problem
encountered by genome-wide studies is power, particularly when searching for rare variants. One approach to
this problem is to perform gene-based or gene-set-based analyses. Over the last three years it has become
apparent that AD risk loci (both common and rare variants) are enriched for myeloid cell expressed genes,
including APOE, TREM2, CD33, SORL1, ABCA7. Microglia are the resident phagocytic cells of the brain and
share a common embryonic lineage with peripheral myeloid cells. We propose to use genomic and functional
approaches to test the hypothesis that microglial function is modulated by AD risk and protective
alleles in genes that are enriched within specific functional networks. This proposal will use publicly available
whole genome/exome sequence data generated by the Alzheimer's Disease Sequencing Project (ADSP) and
genome-wide association study (GWAS) data from the International Genomics of Alzheimer's Project (IGAP)
and others together with gene expression data from purified macrophages and monocytes to identify myeloid
expressed genes that carry rare or common variants that influence risk for AD (Aim 1). By integrating this data
into co-expression networks in monocytes and macrophages we will determine whether AD loci lie within one
or more regulatory networks (Aim 1). To validate these networks and determine the functional consequences
of risk/protective alleles we will perform global transcriptomics and ATACseq in parallel with functional assays
in microglial cells derived from isogenic human iPSC cell lines and mouse BV2 microglial cells, in which
candidate gene expression is knocked-down or mutations are knock-in (Aim 2). Finally, we will use in vivo
knock-down of gene expression specifically in adult microglia to test the physiological consequences of
disrupting an AD-linked functional network (Aim 3). To enable these studies, we have developed a novel
mouse model that can be used to profile the ribosome-bound transcriptome of microglial cells in the brain while
also conditionally and specifically down-regulating the expression of a gene of interest like MS4A6A in
microglia. Using the same model crossed with an AD mouse model, we will investigate AD-related outcomes
like micro-gliosis and ß-amyloid deposition in the context of reduced MS4A6A expression in microglia.
Together these studies will not only further our understanding of the genetic architecture of AD but also provide
key information regarding the molecular mechanisms, setting the stage for novel therapeutic development.

Public health relevance
Project Narrative Alzheimer's disease (AD) is the only disease among the top ten killers in the U.S. without a disease modifying therapy. Recent genetic studies suggest that microglial cell function is a key modulator of risk. The goal of this study is to use state-of-the-art genomics to identify networks of AD risk and protective genes expressed in microglia and to use cell and animal studies to validate the networks and determine the molecular mechanisms of disease, setting the stage for future novel therapeutic development.